Administrative, Leadership Development and Advocacy Core

CORE A: ABSTRACT

The SPORE in Prostate Cancer brings together a highly motivated multidisciplinary team of investigators from
Northwestern University and the University of Chicago, with contributions from NorthShore University
HealthSystem (UC affiliate). The team includes laboratory scientists, urologists, medical oncologists,
pathologists, biostatisticians and bioinformaticians, all of whom are dedicated to conducting state-of-the-art
translational research to develop and test interventions that improve the outcome of patients diagnosed with
prostate cancer.

Public health relevance
CORE A: NARRATIVE The SPORE Administrative, Leadership Development and Advocacy (Admin) Core provides integration and strong leadership and coordinates oversight of projects and cores to ensure that scientific objectives are accomplished such that the SPORE can have the greatest impact on patients with prostate cancer.